Meningeal ectopic lymphoid tissues (mELTs): Composition, organization and expression revealed by imaging and in situ transcriptomics

ABSTRACT
While relapsing-remitting multiple sclerosis (RRMS) can effectively be managed by a pantheon of disease
modifying drugs with anti-inflammatory activities, the transition to secondary progressive MS (SPMS) is met with
refractoriness to therapeutics and a downward spiral of neurodegeneration. This dire scenario has called into
question the role of inflammation in SPMS, and cast SPMS treatment as a pressing unmet clinical need!
However, meningeal ectopic lymphoid tissues (mELTs), which appear during SPMS in pathognomonic fashion,
could drive atypical inflammatory activity and provide novel targets for therapeutic intervention. These
indeterminate structures are B cell-rich aggregates that accumulate in the subarachnoid space of the meninges,
and resemble tertiary lymphoid organs (TLOs) observed elsewhere in the body during various autoimmune and
infectious conditions. In both MS patients and animal models, mELTs are conspicuously located over activated
sub-pial microglia in areas of extensive cortical demyelination and neuronal loss, raising speculation they rain
down as yet unknown incendiary factors that spark “compartmentalized inflammation” and neurodegeneration.
Their role in SPMS etiopathogenesis nevertheless remains ambiguous, as the composition,
compartmentalization, and gene expression of the varied cell types comprising mELTs have not been evaluated
in relation to disease status and locale along the CNS axis – factors that can significantly impact the meninges
and, thus, potentially mELTs. Technical hurdles had precluded examining these issues, but methodological
advances by this group now allow for interrogation of mELTs – histologically and transcriptionally – within their
native meningeal habitat. Two broad Aims are thus proposed to fill these major gaps, and test the hypothesis
The cellular composition, organization and gene expression of meningeal Ectopic Lymphoid Tissues
(mELTs) depend on CNS locale and disease status. Aim 1 will analyze animals at early and late stages of
secondary progressive disease, and characterize the cell composition of mELTs in brain and spinal cord.
Emphasis will be placed on identifying immune, stromal cell and vascular cell types found in known TLOs, and
detailing their 3D organization with respect to each other and meningeal elements. Attention to meninges will
be critical, as meningeal trabeculae might nucleate mELT assembly and/or segregate mELT cells into functional
domains. High-resolution, 3D fluorescence microscopy and immuno-scanning electron microscopy will be used
to view mELT cell organization at the light microscopic and ultrastructural levels, respectively, and imaging mass
cytometry to reveal the full repertoire of cells in context with meningeal structures. Aim 2 will dissect the
respective transcriptomes of the different mELT cell populations in brain and spinal cord in situ during early and
late disease, using laser capture microdissection coupled to RNA-seq to preserve context-dependent gene
expression patterns. This deliberative and methodical spatiotemporal analysis will yield foundational information
necessary for resolving the contribution of mELTs to SPMS and highlighting new therapeutic prospects.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis (MS) remains an insidious disease, with unpredictable outcomes. Though the typical form of the disease, in which there are relapses and remissions, is responsive to many new medications, ultimately nearly seventy percent of patients go onto a secondary progressive phase for which there is currently no effective treatment. This application details experiments to understand the make-up and function of particular structures that appear in the brain and spinal cord uniquely during this progressive phase – meningeal ectopic lymphoid tissues (mELTs) – potentially highlighting new therapeutic treatments for progressive MS.